Targeting aVb8 integrin to restore astrocyte-microglia crosstalk to treat Alzheimer's disease

PHASE I APPLICATION
(STTR Program PAS-22-197)
“Targeting aVb8 integrin to restore astrocyte-microglia crosstalk to treat Alzheimer’s disease”
ABSTRACT
Alzheimer’s disease (AD) is the most prevalent neurodegenerative disorder. Emerging evidence shows that
homeostatic dysregulation of the brain immune system, especially that orchestrated by microglia, plays a
significant role in the onset and progression of the disease. We previously identified a central role for TGFβ5 and
the TGFb-activating integrin, aVb8 (ITGB8), in regulating and developing homeostatic microglia6. We recently
discovered that ITGB8 is highly expressed on astrocytes in patients with AD, especially those expressing
APOE4, the strongest genetic risk factor for AD6, and that ITGB8 expression is associated with increased TGFb
signalling in neurodegenerative microglia (MGnD)7, also known as disease-associated microglia (DAM)8.
Mechanistically, we found that an APOE4-ITGB8-TGFb pathway impairs microglia-astrocyte response to AD
pathology7, and that blocking ITGB8 in AD mouse models restores microglial to a neuroprotective MGnD state8-
10, which mitigates pathology and improves cognition7. The major question relates to microglia-based approach
to treat AD is how to modulate microglia phenotype and function. Preservation of neuronal cells from Aβ induced
apoptosis as well as restoration of resident microglial homeostatic function is critical for the brain function.
The goal of this proposal is to test whether pharmacological inhibition of ITGB8 with a new humanized
mAb, ADWA11, can safely and effectively restore microglia-astrocyte responses as a therapy for AD, that will
lead to development of novel AD treatment. An early version of ADWA11 is currently in Phase 1 clinical trial to
treat solid tumors (Clinical Trial: NCT04152018), which has been well-tolerated in humans. Our preliminary data
demonstrated that systemic administration of humanized ITGB8-blocking antibody enhances an MGnD
phenotype, ameliorates AD pathology, and improves cognition. We propose a multidisciplinary approach
integrating novel tools, experimental paradigms, and deep expertise in microglia (Oleg Butovsky, Brigham and
Women's Hospital/Harvard Medical School), blood-brain barrier (BBB) and astrocytes and integrin biology
(Thomas Arnold, UCSF), to determine the efficacy and safety of a novel high-affinity human ITGB8-blocking
mAb, ADWA11, to restore microglial functions as a treatment for AD. We will address our hypothesis with the
following aims:
Aim 1: Determine targeting kinetics of hADWA11 to induce MGnD phenotype in human iPSC-derived
astrocyte-microglia crosstalk.
Aim 2: Establish PK/PD, biodistribution, and target engagement for hADWA11 in APOE4:5xFAD AD mice.
Aim 3: Determine whether chronic systemic treatment with hADWA11 can ameliorate cognitive
impairment and neurodegeneration in humanized APOE4:5xFAD mice.
Based on the results of this work we will be able to develop a first in class antibody-based treatment to restore
microglial functions for treatment of Alzheimer’s disease, and particularly for AD APOE4 carriers.

Public health relevance
PROJECT NARRATIVE This STTR Phase 1 proposal will investigate the potential for blocking ITGB8-TGFb signaling to treat Alzheimer’s disease (AD). We found that 1) APOE4-microglia are impaired to respond to neurodegeneration via ITGB8-TGFb1 signaling in AD; and 2) Targeting ITGB8-TGFb1 axis restores microglial response to neurodegeneration associated with reduced neuropathology. Using a new pharmacological blocker of ITGB8, humanized ADWA11 mAb, novel mouse models and tools we will establish in vitro targeting kinetics, in vivo PK/PD and efficacy in humanized AD mouse model and lay the foundation for anticipated STTR2 and related future clinical trials.